Optical Aberration and Visual Performance for Highly Aberrated Eyes

? DESCRIPTION (provided by applicant): The goal of this competitive renewal is to translate laboratory research on wavefront-guided scleral contact lenses into a clinical solution for highly aberrated eyes that restores retinal image quality to normal or better than normal levels. This will be accomplished by identifying and removing barriers that currently complicate clinical translation. Completion of this goal will allow the research team to test the hypotheses that: 1) A mature visual system (having experienced good retinal image quality during the formative years) that is now habitually experiencing poor retinal image quality due to elevated higher order aberrations will, with time, adapt back to normal levels of visual performance (visual acuity, contrast sensitivity as a function of letter size and stereo-acuity); and 2) normal or better than normal retinal image quality provided by wavefront guided corrections improves quality of life in patients with highly aberrated eyes compared to clinically available non-wavefront guided corrections.

Public health relevance
PUBLIC HEALTH RELEVANCE: Typical causes of highly aberrated eyes (keratoconus, corneal marginal dystrophy, poor refractive surgery outcome, etc.) occur during the most productive years of life (years of education, earning power, child bearing). The work proposed here immediately transfers laboratory research into clinical care that reduces visual impairment by improving the quality of vision to normal levels in these individuals and increases our understanding of the visual system.